Considerations of covariates in biomarker studies

[unreadable] DESCRIPTION (provided by applicant): Methodology for evaluating biomarker studies lags far behind that for evaluating therapeutic and epidemiologic studies. For example, the notion of covariate adjustment is well established in therapeutic and epidemiologic research for proper evaluation of therapeutic and exposure effects. However, in biomarker research, covariate adjustment has not yet been defined. Also, in epidemiology there is a clear understanding of the attributes and limitations of matching controls to cases, but not in biomarker research. Factors that are correlated with the biomarker and/or disease are termed covariates. There are many examples, including subject characteristics (e.g., age is associated with PSA levels and with risk of prostate cancer in men), collection and processing factors (e.g., the biomarker may vary with the covariate study site in a multicenter study) and disease characteristics (e.g., the biomarker may vary with histology or stage of the cancer). We believe that without proper adjustment for covariates the receiver operating characteristic (ROC) curve for a biomarker can be biased. Moreover, comparisons between biomarkers can be invalid. Importantly, matching of controls to cases in study design does not obviate the need for covariate adjustment: bias and invalid comparisons of biomarkers can still result. We propose to develop an understanding of the various roles of covariates in biomarker evaluations and to develop simple techniques for including them in data analyses. We will address covariate adjustment in the evaluation of a biomarker's performance with the ROC curve (Aim 1), in making comparisons between biomarkers (Aim 2(i)) and in evaluating variations in the performance of a biomarker (Aim 2(ii)). In Aim 3 a detailed study of the attributes and limitations of matching controls to cases in study design will be undertaken. In many settings existing clinical factors or biomarkers are predictive and the goal in studying a new marker is to evaluate its added benefit. Methods for evaluating this, the incremental value of a marker, will be studied in Aim 4. Phase 2 studies conducted by the Early Detection Research Network (EDRN) will provide context for our work. Programs written in Stata will be made available through the Stata archive, the EDRN and through a 'Diagnostics and Biomarkers Statistical Center' web site. [unreadable] [unreadable] [unreadable]